Oral Complex Carbohydrate Sensing

SUMMARY
Carbohydrates play a significant role in the human diet and the extent of their consumption directly impacts
human health. In order to control carbohydrate consumption, it is critical to understand how the gustatory system
responds to them. Recently, we reported that humans can taste glucose-based oligosaccharides and that their
detection is independent of the known sweet receptor. Building upon these findings, this proposal seeks to
establish the range of oligosaccharides that humans can taste and further to determine the structural
characteristics of oligosaccharides that enable their perception by humans. This project has two overarching
hypotheses: (1) that humans can taste a wide range of oligosaccharides, and (2) that taste detection depends
on the molecular structures of oligosaccharides with respect to the types of monomer building blocks, chain
length, position and number of glycosidic linkages, and terminal residues. These two hypotheses will be tested
by using a range of naturally existing, well-defined oligosaccharides and selected derivatives. Two functionally
different groups of oligosaccharides will be considered: (a) starch-derived digestible oligosaccharides that are
primary sources of dietary energy and (b) non-starch oligosaccharides that are not digested by humans but are
considered beneficial to health (e.g., prebiotics). Recognizing that commercially available oligosaccharides are
heterogeneous “cocktails” with undefined profiles, we propose to purify or isolate target oligosaccharides.
Accordingly, an important additional outcome of this project will be publically available protocols for the
preparation of well-defined, natural and derivatized oligosaccharides for human testing. These compounds
should prove to be valuable candidate ligands for future studies aimed at the molecular characterization of
oligosaccharide receptor(s).

Public health relevance
NARRATIVE Complex carbohydrates are abundant in the human diet and their consumption is directly linked to overall health. For example, prolonged consumption of diets high in digestible carbohydrates have been linked with obesity and type 2 diabetes. The proposed project will contribute to our understanding of the nature of human gustatory perception of complex carbohydrates with the long-term goal of developing strategies to modulate carbohydrate consumption.